PROGERIN ENDOTHELIAL DYSFUNCTION AND VASCULAR DISEASE

DESCRIPTION (provided by applicant): Vascular diseases, in particular atherosclerosis and its complications (e.g., myocardial infarction and stroke), continue to be a major public health problem that afflicts millions of people in the United States and other countries. Given their inherently complex and variable nature, the study of monogenic forms of some types of vascular disease (e.g., familial hyperlipidemias and atherosclerosis) can greatly assist in elucidating their pathogenesis. The recent discovery of the genetic basis of Hutchinson-Gilford Progeria Syndrome (HGPS) provides such an opportunity. HGPS is a premature aging disorder in which affected children have normal appearance at birth, but begin to age rapidly within 1-2 years. This disease affects multiple organ systems, including the heart and blood vessels. Indeed, the most prominent and fatal feature of HGPS is premature and accelerated atherosclerosis resulting in heart attacks and strokes. HGPS is caused by a single point mutation in the LMNA gene, which results in accumulation of a mutant form of the lamin A protein called Progerin. The central hypothesis of this project is that Progerin accumulation in vascular endothelium results in chronic endothelial dysfunction, contributing to the onset of vascular pathologies documented in patients with HGPS, and potentially also in normal individuals with aging. In the first specific aim, we will dissect the molecular pathways activated in Progerin-expressing cultured EC that lead to chronic endothelial dysfunction. In the second specific aim, we will elucidate the paracrine effects that endothelial-derived, Progerin- stimulated mediators (such as interleukin-1) exert on vascular smooth muscle cells. In the third specific aim, we will investigate the pathophysiological consequences of endothelial-specific expression of Progerin in vivo in a novel transgenic murine model. These studies should provide important mechanistic insights into the cellular and molecular causes of vascular disease in HGPS patients, and may suggest new therapeutic strategies for other vascular diseases in which endothelial dysfunction plays a pathogenic role.

Public health relevance
PUBLIC HEALTH RELEVANCE: Several human diseases are associated with aging; among these are atherosclerosis and its consequences, heart attacks and strokes. Children with a genetic mutation in a specific gene develop a syndrome of premature aging called Progeria. They develop atherosclerotic plaques, and are prone to heart attacks and strokes. We propose to understand how this mutation triggers the development of cardiovascular disease in children with Progeria. Results from these studies, involving a specific gene linked to the development of vascular disease, will hopefully indicate new ways to treat children with Progeria and may also lead to innovative strategies to diagnose, prevent, and treat heart disease in the general population. "PROGERIN, ENDOTHELIAL DYSFUNCTION, AND VASCULAR DISEASE" PROJECT NARRATIVE Several human diseases are associated with aging; among these are atherosclerosis and its consequences, heart attacks and strokes. Children with a genetic mutation in a specific gene develop a syndrome of premature aging called Progeria. They develop atherosclerotic plaques, and are prone to heart attacks and strokes. We propose to understand how this mutation triggers the development of cardiovascular disease in children with Progeria. Results from these studies, involving a specific gene linked to the development of vascular disease, will hopefully indicate new ways to treat children with Progeria and may also lead to innovative strategies to diagnose, prevent, and treat heart disease in the general population. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Vascular diseases in particular, atherosclerosis and its complications (e.g., myocardial infarction and stroke), continue to be a major public health problem that afflicts millions of people in the United States and other countries. Given their inherently complex and variable nature, the study of monogenic forms of some types of vascular disease (e.g., familial hyperlipidemias and atherosclerosis), can greatly assist in elucidating their pathogenesis. The recent discovery of the genetic basis of Hutchinson-Gilford Progeria Syndrome (HGPS) provides such an opportunity. HGPS is a premature aging disorder in which affected children have normal appearance at birth, but begin to age rapidly within 1-2 years. This disease affects multiple organ systems, including the heart and blood vessels. Indeed, the most prominent and fatal feature of HGPS is premature and accelerated atherosclerosis resulting in heart attacks and strokes. HGPS is caused by a single point mutation in the LMNA gene (encoding for lamins A and C which are components of the nuclear lamina), which results in accumulation of a mutant form of the lamin A protein called Progerin. While several lines of investigation have begun to probe the vascular defects associated with HGPS, the specific involvement of the vascular endothelium in the pathogenesis of the vascular disease associated with HGPS remains unexplored. Our laboratory and others have shown that endothelial dysfunction, which reflects a multi-faceted impairment of the vital functions of the lining of the heart and blood vessels, is an early critical event in the development of vascular disease. Given that Progerin has been shown to be highly expressed in vascular cells (including endothelial cells) in HGPS, we propose to investigate the hypothesis that Progerin accumulation in vascular endothelium leads to chronic endothelial dysfunction, focusing in particular on the underlying molecular mechanisms of endothelial dysfunction that lead to the onset of vascular pathologies in patients suffering from HGPS. Towards this goal, in this research program we propose to develop in vitro and in vivo models of Progerin-expressing vascular endothelium, and to utilize these to explore the pathogenic mechanisms of HGPS-associated vascular disease, as described in the following three Specific Aims. SPECIFIC AIM 1: Dissect the Molecular Pathways Activated in Progerin-expressing Cultured Endothelial Cells that lead to Endothelial Activation and Dysfunction. Hypothesis/Rationale: It is our working hypothesis that accumulation of Progerin in endothelial cells (EC) leads to chronic endothelial dysfunction, manifested as changes in the normal (anti-inflammatory, anti-thrombotic) endothelial functional phenotype, which are a consequence of critical changes in gene expression. In this aim, we will define the transcriptional programs and signaling pathways through which Progerin-expressing EC initiate and maintain a dysfunctional phenotype. These studies will make use of a novel in vitro model of viral- mediated Progerin expression in cultured human endothelial cells. Experimental Approach: A. Analyze the dysregulation of transcriptional activity in Progerin-expressing endothelial cells utilizing genome-wide methods of analysis. B. Examine the role of autocrine effects mediated by endothelial-derived interleukin-1 (and potentially other mediators) in the initiation and maintenance of endothelial activation and dysfunction in Progerin- expressing endothelial cells. C. Assess the role of dysregulation of KLF2 expression in the Progerin-induced endothelial dysfunctional phenotype. Significance: These studies should provide novel insights into the mechanisms by which Progerin-expressing EC become dysfunctional, and importantly, will uncover specific signal transduction pathways induced by Progerin expression in EC. The identification of endothelial-derived Progerin-dependent products will be critical for our understanding of autocrine and paracrine effects of these factors in the context of vascular wall pathophysiology. SPECIFIC AIM 2: Elucidate the Paracrine Effects of Endothelial-derived, Progerin-dependent mediators on Smooth Muscle Cells. Hypothesis/Rationale: Post-mortem studies of HGPS patients, and histopathologic studies of recently developed mouse models of Progerin overexpression have documented severe vascular defects, including a profound loss of vascular smooth muscle cells in the medial layer of large arteries. Given that EC and vascular smooth muscle cells (SMC) interact to regulate many important integrated vascular functions (e.g., vessel tone, vascular remodeling), we hypothesize that EC expressing Progerin may exert paracrine effects to modulate the function and phenotype of neighboring SMC. Thus, in this aim, we will characterize the pathophysiological responses of SMC to the mediators generated by Progerin-expressing EC, and identify the critical endothelial-derived mediator(s) responsible for these SMC responses. Experimental Approach: A. Define the contribution of interleukin-1 (α and β) produced by Progerin-expressing endothelial cells to changes in vascular smooth muscle cell phenotype. B. Characterize the paracrine responses of endothelial-derived factors, in addition to interleukin-1, generated by Progerin-expressing endothelial cells on vascular smooth muscle cells. Significance: The proposed studies should reveal a mechanistic link between Progerin expression in EC, endothelial dysfunction, and paracrine effects on SMC resulting in altered smooth muscle cell function and phenotype. These insights will be important for the assessment of cellular phenotypes at the level of the vascular wall of the in vivo experiments proposed in Specific Aim 3. SPECIFIC AIM 3: Investigate the Pathophysiological Effects of Endothelial-specific Progerin Expression in vivo in a novel transgenic mouse model. Hypothesis/Rationale: We hypothesize that endothelial cells (EC) expressing Progerin play an important role in the pathogenesis of the documented vascular defects in patients with HGPS. In this Specific Aim, we will determine if the phenotypic features of Progerin-expressing endothelial cells, the autocrine effects on these cells and paracrine effects on smooth muscle cells documented in Specific Aims 1 and 2 translate into integrative pathophysiological changes at the level of the vessel wall in vivo. In particular, the experiments proposed here will allow us to test the hypothesis that the vascular endothelium acts as a mediator of the complex vascular pathologies observed in HGPS, and potentially certain of the vascular changes associated with aging. Experimental Approach: A. Basic characterization of our recently developed transgenic mouse expressing Progerin selectively in vascular endothelium (EC-Pg Tg). B. Further documentation of vascular pathologies developed in EC-Pg Tg Mice. C. Define the effects of Statin treatment on the vascular pathologies displayed in EC-Pg Tg mice. Significance: The characterization of our recently developed EC-Pg Tg mice will be critical in exploring the role of endothelial-expression of Progerin in the pathophysiology of endothelial dysfunction and vascular disease. Importantly, we anticipate that this model will assist in defining the natural history and molecular mechanisms of HGPS, and will be useful in the future for the design and testing of potential therapeutic approaches to prevent/ameliorate endothelial dysfunction in several pathological settings, including the aging process in otherwise healthy individuals.